Diabetes, Endocrinology and Metabolism Training Grant

Project Summary
The T32 Training Program in Diabetes, Endocrinology and Metabolism at Stanford University (Endocrine T32)
serves a national need to train physician and basic scientists in the fields of diabetes, endocrinology and
metabolism. The Endocrine T32 has a remarkable 46-year record of rigorous scientific training; producing
numerous current and emerging endocrine research leaders. The goal of this renewal is steadfast pursuit of this
critical purpose. The Endocrine T32, the only postdoctoral research training program in diabetes, endocrinology
and metabolism at Stanford, is integrated into an extraordinary research environment, including the Stanford
Diabetes Research Center, and unparalleled training activities, seminars and resources. The training program
will provide M.D. and Ph.D. postdoctoral trainees (four per year, evenly split), a uniquely rich and supportive
environment to learn innovative research approaches. Supported by the Endocrine T32 for two years, trainees
will pursue cutting-edge research in the laboratories of remarkably accomplished investigators and experienced
mentors. The training faculty include 28 investigators from nine basic science and clinical Departments, whose
interests converge on four themes (Islet and Beta-cell Biology; Obesity, Metabolism and Diabetes Complications;
Interventional and Population Diabetes; Endocrinology and Population Health Sciences); integrating a wide
spectrum of diabetes- and endocrinology-focused laboratory, clinical, translational, epidemiologic and health
disparities research. Mentors will participate in formal training workshops to ensure supportive and inclusive
training. Trainees will receive a structured curriculum of study that includes weekly seminars, an Endocrine T32
specific series (where they present and critique the work of others) and career-pertinent didactic courses,
including the Responsible Conduct of Research, biostatistics and computation/computer programming. These
efforts foster a stimulating, cohesive and productive training experience that engenders the knowledge and skills
necessary to emerge research leaders. To safeguard trainee success, they will formulate a Career Development
Committee that assesses research progress, encourages professional development and co-navigates the trepid
transition to independence. Over the past 15 years, 85% of our trainees have remained in science; to continue
this success, trainees will develop and submit Career Award applications through participation in grant-writing
bootcamp. In recognition of the challenging, long gestation of (physician) scientists, robust (>$300,000 per year)
institutional support that augments trainee salary and bridge funding will be provided. The Program will take
concrete steps to address a historic lack of inclusivity, including Internal and External Advisory Committees with
expertise in the recruitment and retention of underrepresented individuals and that ensure programmatic
accountability. The goal of this Training Grant is to educate a diverse cadre of promising postdoctoral (physician)
scientists that become the future leaders of academic, governmental and industrial in endocrine research.

Public health relevance
PROJECT NARRATIVE The purpose of this Training Grant is to prepare qualified postdoctoral trainees in Endocrinology, Diabetes and Metabolism for scientific research careers that significantly impact on the health-related research needs of the United States. This training program will utilize Stanford University’s world-class faculty and resources in the fields of basic, translational and population health research in endocrinology with a primary focus on diabetes. Trainees who graduate from this program will be well-prepared to independently lead (within an academic or industrial setting), create and apply new scientific discoveries that enhance public health in areas of diabetes, obesity, bone health and hormone-dependent cancer.